Development of Metallopeptides for Site-Selective Transformations of the Antibiotic Thiostrepton

Project Summary
Catalysis is an enabling technology for selective synthesis in organic chemistry. In the
majority of transformations, catalysts are based on distinct homogeneous, heterogeneous, or
enzymatic platforms, enabling high chemo- and site-selectivity for a particular transformation.
However, when substrates become more complex, including for the functionalization of natural
products, traditional catalytic methods can become incompatible with the functional group
complexity of these molecules. Therefore, there is motivation to develop site-selective catalysts
that are compatible with the molecules at the frontier of human health efforts.
One approach to achieving enzyme-like selectivity is the use of synthetic peptide
catalysts. Similar to enzymes, synthetic peptides have chirality, can participate in a variety of
covalent or non-covalent interactions, and can also have a secondary structure to create an
active site for catalysis. To date, peptide catalysts have been developed for organo-catalyzed
transformations but are in the early stages of potential application in transition metal catalyzed
reactions. This proposal will develop peptide-containing transition metal catalysts for the site-
selective transformations of complex targets. In particular, due to the rapid development of
antibiotic resistance, the late-stage functionalization of antibiotics is of particular relevance to
human health efforts. To begin our efforts, the potent, structurally complex antibiotic thiostrepton
has been selected for this purpose. Thiostrepton is not currently used in the clinic due to poor
pharmacokinetic properties; therefore, modification of thiostrepton using these catalysis offers
the exciting potential to develop new, more potent antibiotics. We will specifically develop site-
selective hydrogenation and additional transition metal catalyzed reactions for the synthesis of
derivatives and development of structure-activity relationships that could be used to design new
thiopeptide antibiotics.
Towards these goals, the following aims have been developed:
1) Identification of Transition Metal Catalysts for the Enantioselective Functionalization of
Thiostrepton
2) Development of Peptide-Containing Catalysts for Site-Selective Hydrogenation
3) Expansion of Methods for Site-Selective Modification of Thiostrepton
With these Aims, design principles for site-selective catalysis will be uncovered, significantly
contributing to known methods for the synthesis of molecules with potentially improved
bioactivity.
1

Public health relevance
Project Narrative This proposal seeks to develop new methods for the site-selective transformation of complex molecules. Metallopeptide catalysts will be designed and applied for the selective functionalization of thiostrepton, a potent antibiotic. The insights from this study will enable design principles for the late-stage functionalization of bioactive molecules relevant to human health. 1